A Multifactorial Mechanism for Alzheimer's Disease

Project Summary
There is a dramatic increase in the prevalence of dementia among veterans, because of the aging
of the veteran population and a high prevalence of dementia risk factors among veterans.
Alzheimer’s disease (AD) is the most predominant neurodegenerative disorder linked to
dementia. This project aims to identify key molecules and mechanisms that link pathological
abnormalities to cognitive impairment in AD. Our transcriptomic analysis of large-scale
postmortem AD human prefrontal cortex (PFC) data has revealed that the upregulated genes are
prominently enriched in the complement pathway, and our epigenomic analysis has identified
ADNP (Activity-Dependent Neuroprotective Protein), a chromatin regulator strongly linked to
intellectual disability, as the top-ranking transcription factor regulating the elevated complement
genes in AD. Our preliminary data have shown that ADNP and its partner HP1 (Heterochromatin
protein 1) are significantly diminished in postmortem AD human PFC. ADNP knockdown in mouse
PFC induces genetic dysregulation, synaptic dysfunction, microglia activation and behavioral
abnormalities reminiscent of a familial AD mouse model, 5xFAD. Thus, we hypothesize that the
ADNP-mediated chromatin dysregulation leads to complement activation due to the disrupted
gene repression, which triggers microglia activation and synapse loss by phagocytosis, resulting
in cognitive impairment. To test this, multidisciplinary approaches will be used to address 3
specific aims. Aim 1. To investigate the role of ADNP in the elevation of complement genes in
AD. Aim 2. To investigate the impact of ADNP and complement system on synaptic dysfunction
and cognitive deficits in AD mouse models. Aim 3. To investigate the therapeutic potential of
manipulating ADNP and complement system in human iPSC-derived neuronal cultures from AD
patients. Results gained from this study will reveal novel mechanisms on AD pathophysiology,
and provide great promise for the discovery of mechanism-based therapies to treat AD.

Public health relevance
Project Narrative This project will use mouse models and human stem cell-derived neuronal cultures to test the hypothesis that the deficiency of chromatin regulator ADNP (Activity-Dependent Neuroprotective Protein) in Alzheimer's disease (AD) leads to the elevation of complement genes, microglia activation and synapse elimination, resulting in cognitive impairment.